Experimental Cellular Approaches to Genotype × Environment Interaction

PROJECT SUMMARY
We propose to perform a novel study in the field of cellular epidemiology, that has been made possible by
the recent revolution in induced pluripotent stem cell (iPSC) technology. It is well known that there are many cell-
specific functions and behaviors that have been missed by the limitations of having to rely on easily obtainable
cells, such as blood cells or lymphoblastoid cell lines, for epidemiological studies of disease causation, risk
factors, and biomarker identification. Advances in iPSC technologies now allow us to consider non-invasive
large-scale deep cellular phenotyping efforts on disease-appropriate cell types in human subjects. Robust
derivation of iPSC lines and their differentiation into organ-specific cell types is possible from blood cells. An
important benefit of iPSC-derived cells is that observed biological variation primarily represents genetic
influences, since most of the epigenetic memory of the historical organismal environment is lost.
Our proposed study involves an innovative experimental approach to human genotype×environment
interaction (GEI). While GEI is thought to exist widely, it is relatively poorly studied in humans due to
environmental heterogeneity and the difficulty of controlling environmental exposures. Our iPSC-based cellular
approach allows us to rigorously test for GEI experimentally by examining cellular phenotypic variation before
and after a controlled environmental challenge. Our study will be the first and largest study to model human GEI
in two different iPSC-derived cell types. First, we will determine if the expected neurotoxic effect of snake venom
in neural stem cells (NSCs) is genetically driven, and secondly, whether the suspected differential response of
alveolar epithelial type 2 cells (AT2s) to environmental pollutant exposure has a genetic basis.
This project will leverage a major existing human resource, the Mexican American Family Study (MAFS). We
will use existing cryo-preserved iPSC lines from 400 MAFS participants for the generation of well-characterized
NSCs and AT2. We propose a novel experimental and efficient pedigree-based approach for studying the genetic
basis of cellular response to environmental stress (i.e, GEI), which has previously been difficult to assess. Our
aims are: 1) assess genetic basis of NSC response to snake venom; 2) assess genetic basis of AT2 response
to a benzo[a]pyrene pollution; 3) examine the genetic basis of environmental disruption of cellular transcriptional
coherence/homeostasis; and 4) identify pleiotropic effects of cellular stress resilience on human organismal
phenotypes relevant to health.
This project will employ a novel experimental and efficient pedigree-based approach for studying human GEI,
which has previously been difficult to assess. It also will help establish the feasibility of epidemiological scale
utilization of iPSC technology to attack biomedical problems. Finally, we expect that the proposed project will
rigorously establish the cellular basis of GEI influencing complex phenotypes of relevance to human health.

Public health relevance
PROJECT NARRATIVE It is well known that there are many cell-specific functions and behaviors that have been missed by the limitations of having to rely on easily obtainable cells such as blood cells or lymphoblastoid cell lines for epidemiological studies of disease causation, risk factors, and biomarker identification. Advances in iPSC technologies now allow us to consider non-invasive large-scale deep cellular phenotyping efforts on disease-appropriate cell types in human subjects from easily obtained blood cells. Using a rigorous experimental approach benefiting from subjects from extended pedigrees, we propose to test for genotype×environment interaction (GEI) experimentally by examining cellular phenotypic variation before and after a controlled environmental stress challenge. We expect that the proposed project will establish the cellular basis of GEI influencing complex phenotypes of relevance to human health.